Behavioral Parenting Skills as a Novel Target for Improving Pediatric Medication Adherence

Abstract
This parent grant (R01CA258337-01A1) for this supplement focuses on the relationship between parenting
skills and medication adherence in young children diagnosed with acute lymphoblastic leukemia (ALL), the
most common pediatric cancer. Parents are tasked with giving daily medications for oral chemotherapy at
home, an experience that can be marked by parent-child conflict, logistical difficulties, and distress. In order to
develop an intervention to minimize barriers to successful medication administration, it is critical to understand
parental skills, behaviors, and experiences with giving pediatric cancer patients medication at-home. One of
the aims of this parent grant-funded study uses direct observation of medication administration via video
recording in the home to collect objective data to characterize the specific parenting experiences at the daily
and episode levels that shape medication administration in young children. Initial reviews of video-recorded
direct observations of parents administering medications point to an opportunity to augment the existing
quantitative coding schemes with newly developed qualitative coding schemes. The candidate for this
supplement will benefit from the opportunity to expand her existing research expertise in caregiving science by
creating a qualitative coding scheme that captures nuanced contextual data about medication administration in
the home setting. The candidate for this supplement will also build on the parent project by analyzing
associations between parents' sociodemographic data and medication administration in order to identify
potential patterns of disparities in medication adherence outcomes, thus contributing to her goal to strengthen
her experience in disparities research. Finally, in order to fulfill the candidate's goal of broadening her
expertise in health literacy, she will extend the parent project's aim of considering parental health literacy as a
potential correlate of medication adherence experiences by conducting additional analysis of the health literacy
variable to identify potential associations with parental caregiver's sociodemographic traits. Findings from
these activities will fill gaps in knowledge about modifiable factors (caregiver behaviors and health literacy
skills) that can be addressed via targeted interventions to improve patient outcomes and mitigate disparities.

Public health relevance
Project Narrative The purpose of this supplement application is to extend and enhance research from parent grant (R01CA258337-01A1) examining parental and family caregivers’ experiences in ensuring medication adherence in pediatric cancer patients. Findings from the supplement’s proposed activities will fill gaps in knowledge about modifiable factors that can be addressed via targeted interventions to improve patient outcomes. This training opportunity will allow the candidate to pursue their career goal of developing interventions to mitigate disparities in cancer populations.